Studies on the Prevalence, Risk Factors and Outcomes of Cancers in HIV in India

DESCRIPTION (provided by applicant): Globally, India has one of the largest populations of HIV-infected people, estimated at 2.40 million individuals. Malignancy is a known co-morbidity of HIV infection and is growing in proportion in many parts of the world. The incidence and manifestations of cancer in HIV-infected individuals in India has not yet been well characterized, and the proportion of patients with undiagnosed HIV infection who may be presenting with cancer as their first manifestation of HIV infection is not known. The goal of this proposal is to obtain information on the prevalence of HIV in the cancer population seen over a 1-2 year period at a major cancer treatment and referral center in Northern India. We will similarly assess the HIV prevalence of patients presenting to cancer screening clinics at the same institution (e.g. breast, cervical and prostate). Another goal is to collect information; demographics, HIV and clinical status at presentation, HIV and cancer risk factors, as well as information on incidence of cancer, cancer types, stage, treatments and treatment outcomes in patients with HIV and cancer. In addition we will similarly assess various cancer risk factors and the prevalence of various oncogenic viruses in patients with incident cancers (compared to concurrent control HIV+ individuals from the same HIV clinic at the same institution that do not develop cancer in the timeframe of this study. This will allow assessment of HIV prevalence in various cancers types as well as provide information on the short- term cancer incident and various risk factors and co-factors for cancer development among HIV-infected persons. Identified cancer and HIV individuals from this study will be enrolled in a cancer and HIV registry and specimen/tissue bank, which we will help establish, for prospective follow-up and specimen collection to obtain data on cancer and HIV treatments and clinical outcomes and to provide a cohort for future research studies, including epidemiologic, laboratory and possible clinical trial. Establishment of the HIV and cancer registry with collected tumor and blood specimens will provide our Indian investigator colleagues with a valuable resource for further research (with additional future Indian outside funding). This study will involve a collaboration between investigators at UCLA, the All India Institute for Medical Sciences (AIIMS) in New Delhi and the Dr. B.R. Ambedkar Institute and Rotary Cancer Hospital (DR BRAIRCH) at AIIMS The overall goal is to better characterize the important association of HIV and cancer in India and to identify risk factors and potential viral co-factors which may ultimately service as the basis for future therapeutic and prevention interventions for this important co-morbidity in HIV.

Public health relevance
PUBLIC HEALTH RELEVANCE: Determining the prevalence of undiagnosed HIV infection in individuals with cancer presenting to a regional cancer hospital will help the Indian Ministry of Health and the National AIDS Control Organization to understand the linkage of HIV and cancer and allow earlier diagnosis of HIV in this population, thus allowing earlier HIV treatment and increasing the awareness of the greater risks of complications during cancer treatment. Understanding the risk factors and association of various risk factors and oncogenic viruses with cancer development in the HIV population may also help inform future cancer prevention trials in HIV, where cancer related morbidity and mortality is increasing rapidly. Finally establishing an HIV and cancer registry and specimen repository will allow for continued monitoring of cancer and HIV outcomes in this co-morbid population, provide an important resource for future research, and may result in changes in patient management to improve therapeutic outcomes __SpecificAimsTextDelimiter__ SPECIFIC AIMS 1. To conduct a cross-sectional survey of HIV prevalence at a major cancer referral hospital and its associated cancer screening clinics in New Delhi. 2. To investigate the prevalence, short-term incidence and risk factors for cancer in HIV+ individuals being followed regularly in a large HIV clinic in New Delhi 3. To establish an ongoing registry and data base for prospectively collecting information on HIV and cancer risk factors, cancer and HIV treatments and cancer treatment outcomes in HIV patients with cancer and to be able to recall these individuals for future research studies. India has one of the highest numbers of HIV-infected individuals in the world. Cancer, which was known to be associated with AIDS even before HIV was identified, makes up a growing proportion of co-morbidities seen in many parts of the world. The incidence and distribution of cancer in HIV-infected individuals in India has not been well described, and the proportion of the cancer population of India who may have undiagnosed HIV infection and who may be presenting with cancer as their first manifestation of HIV infection is not known. The goal of this proposal is to obtain information on the prevalence of HIV in the cancer population seen at a major cancer center in Northern India and to collect demographic, clinical (including both cancer- and HIV- related information), treatment and outcome data to better characterize the population of HIV-infected individuals with cancer seen at a major referral and teaching center in New Delhi. We also propose a survey of the HIV patients being followed at the HIV clinic at AIIMS for prevalent and incident cases of cancers detected over the two year period of this pilot grant and to collect information and blood specimens on various cancer associated risk factors, with the goal of better characterizing the types and associated factors, including demographics, residence, environmental exposures, viral co-infections, CD4 counts, viral load and other HIV-associated factors, which may affect the type and frequency of tumors in the HIV population. The results from this study may also help better characterize and identify possible targets for future cancer preventive strategies in this population. We will also create an HIV cancer registry with an associated specimen bank to prospectively follow this group of HIV cancer patients to provide longitudinal data and serial serum, plasma and PBMC specimens for future research studies into this growing problem of cancer in HIV. We will also collect prospective information on cancer treatment and outcome of these HIV and cancer patients to help better understand treatment outcomes in this group of patients with the aim of being able to develop future treatment clinical trials to improve therapeutic outcomes. This last aim is to assist in establishing and initiating the registry and associated specimen bank and will require additional funding from Indian sources in order to maintain and optimally utilize this important scientific resource. This study will be conducted at the All India Institute for Medical Sciences (AIIMS) and the Dr. B.R. Ambedkar Institute and Rotary Cancer Hospital (DR BRAIRCH) at AIIMS and its affiliated cancer screening clinics in New Delhi, India. The overall project will be led by Dr. Ronald Mitsuyasu, Group Chair of the AIDS Malignancy Consortium (AMC), US PI, and Dr. Sanjeev Sinha, Director of the HIV Clinic of the All India Institute for Medical Sciences (AIIMS), Indian PI. Dr. Roger Detels, Professor of Epidemiology and Director of the UCLA Multicenter AIDS Cohort (MACS) and Dr. Karabi Nandy of the Biostatistical Core of the UCLA CFAR will be investigators on this project. Dr. Richard Ambinder is also a co- investigator, who will provide his considerable expertise in viral oncogenesis to help direct investigations into viral epidemiology of cancers in HIV.